National Clinical Trials Network Research at the University of Wisconsin

Project Summary/Abstract
The University of Wisconsin Carbone Cancer Center (UWCCC), its leadership, and its faculty are driven by a
mission to defeat cancer through rapid application of groundbreaking research in cancer education, prevention
and treatment. Embedded in the UWCCC's strategic plan are tactics for expanding a modern research platform
inclusive of a comprehensive clinical research program with exemplary data management and clinical trial
prioritization as well as scientific oversight and leadership. The UWCCC NCTN LAPs multi-disciplinary team
remains an integral component of this strategic initiative and collaborates with key faculty to support innovative
translational research for next generation clinical trials within the NCI's National Clinical Trials Network.
Since 1974, UWCCC faculty have functioned as leaders in the development of the NCI cancer cooperative group
program; first within ECOG and then with RTOG, ACOSOG and GOG in the early 2000s. As the NCI and its
NCTN transitioned to a centralized infrastructure in 2014, the UWCCC designed a LAPS team of collaborative
principal investigators by combining the existing broad scientific leadership from three of the primary cooperative
groups (ECOG/ACRIN, NRG and ALLIANCE). This multi-disciplinary approach with leaders from Surgical,
Medical, Radiation and Gynecologic Oncology, facilitated an innovative governance structure to provide
leadership and oversight in prioritization of Phase II/III clinical trials, timely trial activation and robust accrual as
well as the development of junior faculty interested in oncologic clinical research. In the four years since our last
grant submission, the UWCCC LAPS team has provided support for the important genomically-directed clinical
trials as well as those with a focus on advanced imaging, while strengthening our Cancer Center's infrastructure.
This UG1 application seeks support for continuing the NCTN activities within the UWCCC. This partnership
remains an important mechanism for providing a diverse population of cancer patients with novel treatment
approaches, as well as a means for providing resources and support for existing and new leaders within the
NCTN to bring innovative translational projects to Phase II/III clinical trials.

Public health relevance
Project Narrative The University of Wisconsin Comprehensive Cancer Center (UWCCC), in collaboration with the National Clinical Trials Network (NCTN), seeks to bring innovative cancer treatment trials to the population of Wisconsin and its neighboring regions to reduce the burden of cancer. Through leadership in the NCTN Cooperative group program, the UWCCC faculty are working to design the next generation of genomically-directed clinical trials, as well as those that utilize advanced imaging techniques.